INFLUENCE OF SEX HORMONES ON RISK FACTORS FOR HEART DISEASE IN WOMEN WITH NIDDM

This study is designed to investigate the hypothesis that women with Non- Insulin Dependent Diabetes (NIDDM) have higher androgens when compared to nondiabetic women, to an enhanced risk for CAD. This study will determine whether women at risk for development of NIDDM (1st degree relative of individuals w/NIDDM, and/or with a history of gestational DM) have an increase in circulating androgens and will identify associations between measures of insulin sensitivity (SI) and cardiovascular risk.